West Virginia Foodborne Illness Rapid Response Team

West Virginia Foodborne Illness Rapid Response Team Project Summary/Abstract
The primary objective of the West Virginia Foodborne Illness Rapid Response Team (WVRRT) is to
provide effective and efficient multi-agency responses to all-hazards as they relate to food and feed
emergencies which impact West Virginia. Secondary objectives include continuing to build on existing
relationships with other entities. Success in achieving WVRRT’s objectives will be accomplished by
training, data sharing/analysis and transparency in communications with our partners at the Federal,
State, Local and Industry levels.
WVRRT project focuses on maintaining food testing capacities, traceback, and recall response and
building relationships and capacities to conduct foodborne illness surveillance within West Virginia
communities. The team continues to conduct FDA HAF2E surveillance sampling of Food as requested by
WV Department of Agriculture READ Laboratory in partnership with their LFFM plans.
During project period 1, WVRRT will work with West Virginia University (WVU) and Marshall University
(Marshall) during this project to conduct wastewater sampling for Norovirus during the July 2023 Scout
Jamboree in Glen Jean, WV. WVRRT will also be onsite to assist Fayette County Health Department with
opening inspections, routine inspections, follow-up inspections and environmental assessments of all
permitted facilities onsite. WV Bureau for Public Health Office of Epidemiology and Prevention Services
(OEPS) will perform health screening on attendees, monitor syndromic surveillance through the region,
and capture illness data collected during the camp and provide health alerts during the Jamboree. This
event will also include DHHR Center for Threat Preparedness, the WV National Guard, and the WV
Fusion Center. WVRRT will participate in this as part of the ICS system of incident response. Project
period 1 will focus on utilizing data collected through epidemiologic surveillance, monitoring foodborne
illness risk factors and prevention methods, wastewater sampling surveillance to evaluate predictability
of foodborne illness in a community. During project period 2 and 3 WV RRT will continue to work with
WVU, Marshall and OEPS to conduct wastewater sampling in communities and to model response and
predictive capacities for Foodborne Illness in the State of WV.
WVRRT will provide training local health departments to utilize HSCloud System to collect foodborne
illness complaint information so that food histories of complainants can be utilized throughout the state
to find and track potential foodborne illness outbreaks more efficiently during project period 2.
During project period 2 WV RRT will work with OEPS, Local Health Departments, and WV Department of
Agriculture to update the Food and Waterborne Illness Outbreak Response Manual.

Public health relevance
West Virginia Foodborne Illness Rapid Response Team Project Narrative During project period 1, WV RRT will participate in the 2023 National Scout Jamboree in Glenn Jean, WV. In project period 2 the after-action report will be from a tabletop exercise that focuses on responding to outbreak caused by product recalled nationally that was used as an ingredient by home food business it will be called “My House is Your House.” The third project period exercise will be a tabletop exercise that demonstrates how complaint collection to a centralized system can help identify outbreaks within the state.